New Non-Nuceleotide Reverse Transcriptase Inhibitors for Drug Resistant HIV Strains

Abstract
Antiretroviral therapy (ART) for HIV/AIDS is effective in the clinical treatment of HIV-1 infections. Non-nucleoside
reverse transcriptase inhibitors (NNRTIs) are a class of anti-retrovirals playing a major role in the success of
ART. However, the emergence of drug resistant viruses has limited the usefulness of the NNRTIs in many
patients. Thus, new NNRTIs are needed to overcome current NNRTI resistant HIV strains. The goal of this study
is to identify new NNRTIs effective for drug resistant viruses. We have previously discovered two classes of
NNRTIs, diarylanilines (DAANs) and diarylpyridinamines (DAPAs), which are structurally different from the
approved diarylpyrimidine (DAPY)-type drugs etravirine and rilpivirine. Each of the chemical classes can fully
overcome some prevalent NNRTI resistant mutations. However, none of them was effective for all the prevalent
NNRTI resistant HIV-1 variants. To fully overcome the NNRTI resistance, we have identified the key structural
features from each of the chemical classes that are required for effectiveness against drug resistant viruses. We
hypothesize that a compound with structural features effective for drug resistant viruses can be synthesized and
will be effective for viruses resistant to current NNRTIs. To test our hypothesis and to accomplish our goal, we
propose to carry out the following two Specific Aims. Aim 1 is to design and synthesize new diarylaniline (DAAN)
and diarylpyridinamine (DAPA) derivatives to overcome HIV-1 variants resistant to NNRTIs. This aim will be
achieved by designing new NNRTIs that include favorable structural features for overcoming drug resistance
selected from DAANs/DAPAs. Aim 2 is to establish the pharmacological profiles of the new NNRTIs effective
against drug resistant HIV-1. The pharmacological study is aimed at establishing basic/initial pharmacological
profiles to pave the way for future more comprehensive drug-target interaction studies and clinical drug
development. Achieving this aim will provide the essential information to advance the compounds for further
preclinical drug development to mitigate NNRTI resistance. Our chemical synthesis will be supported by
conventional medicinal chemistry and modern molecular modeling. The lead optimization will be guided by well-
established primary and secondary biological testing against wild-type and NNRTI resistant virus, respectively.
The research team is positioned uniquely to conduct this endeavor based on over two decades of anti-HIV
research. With confirmed promising leads already on-hand, coupled with the availability of established bioassay
systems, we feel confident that we can discover and develop new NNRTIs to overcome the prevalent NNRTI
resistant viruses.

Public health relevance
Emergence of drug resistant viruses has limited the usefulness of the NNRTIs in many patients. The project's goal is to identify drug candidate(s) to overcome multiple drug resistance to current NNRTIs. With confirmed promising leads on-hand and the availability of established bioassay systems, we expect to discover new NNRTI agents to overcome prevalent NNRTI resistant viruses.